GASTROINTESTINAL FUNCTION IN THE ELDERLY

The purpose of this study is to determine if basal pancreatic polypeptide (PP) levels are elevated in healthy elderly volunteers, to determine the relative contribution of sham-feeding and meals to the secretion of pancreatic polypeptide, and to determine if glucose intolerance affects PP secretion.